Photoproximity labeling as a tool for epigenetic drug discovery

Project Summary
Over the past two decades significant effort has been directed to the identification of ligands that target
the regulation of epigenetic marks. These post-translational modifications (PTMs) control all aspects of
gene expression and are often deregulated in disease, providing attractive vectors for therapeutic
intervention. Currently, despite significant investment, marketed drugs in this area have generally
arisen from phenotypic screening as opposed to a priori design. One reason for this lack of success is
the high degree of complexity within epigenetic regulation, where a protein target may perform multiple
contradictory roles based upon cellular context. Additionally, the high homology between epigenetic
proteins and their isoforms makes the design of selective inhibitors incredibly challenging. It is therefore
critical that both the protein targets of a given ligand and the downstream epigenetic consequences are
well characterized before clinical evaluation. This presents a singular challenge as epigenetic states
(and therefore epigenetic consequences) differ dramatically between cell types and populations. In this
proposal, we will develop proximity proteomics methods to understand how small molecule ligands
remodel the chromatin microenvironment over time. We will achieve this through the targeted
deployment of iridium catalysts to chromatin via ultrafast split intein splicing. Upon visible light
irradiation, these catalysts activate biotin bearing diazirines within a short radius (through a process
called Dexter energy transfer) which subsequently release molecular nitrogen and a highly reactive
carbene. These carbenes insert into C-H and X-H bonds of biomolecules within ~10 nm, which can be
enriched for downstream ‘omics analysis. This method will be used to monitor the biomolecules that
associate to and dissociate from chromatin following ligand incubation. At short time points, this will
provide target identification as ligand bound proteins no longer interact with chromatin. Following longer
incubation, we will measure the functional effect of inhibition of epigenetic modulators as chromatin
PTMs reach a new steady state. We will apply this method to two important areas of chromatin
regulation that have been the target of intense drug development with limited success, lysine
demethylation and c-myc based transcription. We hope to use this method to shed light on these
important vectors for gene regulation, identifying new protein targets and off-targets of established
inhibitor classes. Broadly, this project will provide a valuable tool to study ligands acting at chromatin
that can be applied to many aspects of nuclear biology and drug development, paving the way for better
drug candidates, and ultimately improving human health.

Public health relevance
Project Narrative The development of ligands that modify epigenetic marks has become an active area of investigation within academia and industry across diverse therapy areas. However, the great promise of this effort has yet to be fully realized due to the complexity of the epigenetic chromatin landscape. In this proposal we describe proximity proteomics methods for mechanism of action elucidation within epigenetic drug discovery, providing a new vector for small molecule screening and analysis.